Biomarker Signatures for Delayed Cerebral Ischemia and Outcome Following Subarachnoid Hemorrhage

Abstract
Subarachnoid hemorrhage (SAH) accounts for 5% of all strokes, has a high mortality and the cost to
society is similar to ischemic stroke since subjects are much younger. Though SAH fatality has decreased
~50% in the last 25 years due to immediate repair of aneurysms, improved medical management and
nimodipine, nearly 1/3 of SAH patients develop delayed cerebral ischemia (DCI) often with cerebral infarction
which is associated with poor outcomes. Though this was thought to be due delayed cerebral vasospasm,
recent studies have shown that decreasing or preventing vasospasm does not improve outcomes. This has led
to alternative hypotheses that combined effects of microvessel thrombosis and vasospasm combined with
cortical spreading ischemia and peripheral and central inflammation may cause DCI. Thus, there is a great
unmet need to assess potential treatment targets that contribute to DCI following SAH in humans and that
could be used to predict DCI to begin early treatment and to predict outcome to better allocate resources. The
premise of the proposal is based upon the findings that we have shown that gene expression in blood can
predict SAH patients who develop vasospasm. This led us to Hypothesize that clotting and inflammatory
molecules in blood interact with the brain microvasculature and other factors to cause Delayed Cerebral
Ischemia (DCI) and delayed cerebral infarction following SAH which lead to poor outcomes. We propose that
gene profiles in blood will predict DCI and predict outcomes using the modified Rankin Scale (mRS).
R61 Phase. Specific Aim #1a: Perform RNA sequencing (RNAseq) on whole blood of a training cohort
of patients 1, 2 and 3 days after a SAH but prior to DCI compared to matched vascular risk factor controls.
Specific Aim #1b. Identify the most significantly regulated genes and pathways in blood at 1, 2 or 3d that
distinguish SAH patients who develop DCI at 4-14 days from SAH patients who do not develop DCI. Specific
Aim #1c: Use WGCNA to identify key hub genes and upstream genes expressed at 1, 2 or 3d after SAH and
which are associated with developing DCI at 4-14d and might be causative. Specific Aim #1d. Use Support
Vector Machine (SVM) learning to identify the least number of genes at 1, 2 or 3d from Aim #1b that best
predict (1) SAH patients who develop DCI at 4-14 days (2) and predict mRS of 0, 1-3, 4-5, and 6 at 3 months.
Specific Aim #1e. Confirm RNAseq with qRT-PCR and assess qRT-PCR accuracy and precision.
R33 Phase. Specific Aim #2. In a separate validation cohort of SAH patients perform qRT-PCR on their
peripheral blood to measure expression of genes derived in Aim #1 to predict using Support Vector Machine
(SVM) on day 1, 2 and/or day 3 which patients will develop DCI at 4-14 days and which patients will have
mRS=0 (no deficit), 1-2, 3-5 and mRS=6 (dead) at 3 months.
Contexts of Use. The molecules/pathways that predict DCI and mRS could serve as future treatment or
prevention targets of DCI. Predicting who will develop DCI would make it possible to treat DCI earlier. In
addition, future clinical trials to prevent DCI following SAH would enroll just those patients predicted to develop
DCI after SAH. Predicting mRS outcomes could be used to stratify patients in future DCI trials.

Public health relevance
Narrative This proposal will perform RNAseq on blood of a derivation cohort of subarachnoid hemorrhage (SAH) patients to determine those genes that best predict Delayed Cerebral Ischemia (DCI) between 4 and 14 days and that predict median Rankin Scores (mRS) outcomes at 90 days using cross-correlation. These genes are then measured in an independent validation cohort of SAH patients to predict who develops DCI by 14d, and to predict their mRS at 90 days after SAH. The studies will direct early treatment for DCI, identify treatment targets for DCI, and help stratify patients for future DCI treatment trials.